Delaware Clinical and Translational Research ACCEL Program (Admin Core)

ABSTRACT- ADMINISTRATIVE CORE
The ACCEL CTR Program has successfully met the expectations of this award mechanism by expanding
the capacity for clinical and translational research in Delaware and enhancing our investigators’ ability to
successfully compete for extramural funding in this arena. The success of ACCEL is anchored in the
complementary strengths of the partnership network been built over the past nine years. Our current
network consists of the University of Delaware (lead institution), Christiana Care Health System,
Nemours Children’s Health and Delaware State University—an American, historically Black, public
university. To date, ACCEL has established an exceedingly strong network and infrastructure for clinical
and translational research within Delaware; and, we are now poised and ready to continue our growth
trajectory by building a deeper focus on health equity into our clinical and translational research
infrastructure. The planned components of the ACCEL Program include the Administrative Core and five
other required Cores, including: the Professional Development Core; the Biostatistics, Epidemiology, &
Research Design Core; the Community Engagement & Outreach Core; the Pilot Projects Program, and
the Tracking and Evaluation Core. The overall goal of the Administrative Core is to improve the
efficiency, productivity and impact of the five other Cores so that we are able to successfully meet our
common mission of building clinical and translational research infrastructure that will be sustainable and
ultimately improve the health of Delawareans. We believe that we have a very effective administrative
structure that does not require substantial change. But, in this renewal application, we propose an
exciting new addition to the Administrative Core—a Health Equity Navigator, who will work closely with all
Core leaders to weave the thread of health equity throughout all aspects of the ACCEL program. The
Health Equity Navigator will keep the network focused on health equity as we strengthen our clinical and
translational research infrastructure. The Specific Aims of the Administrative Core are to continue to: (1)
Provide a flexible and efficient administrative and governance structure that enhances the DE-CTR
ACCEL Program’s ability to grow and sustain clinical and translational research programs that address
the most important health care needs of Delawareans and all Americans; (2) Manage the financial and
business operations of the DE-CTR ACCEL Program to ensure operational efficiency, sound fiscal health
of the organization and compliance with all federal, state and local regulations; (3) Enhance and promote
data-informed decision-making, communication and collaboration across all ACCEL components,
participating institutions and other IDeA programs; and (4) Facilitate the implementation of strategic, high-
value initiatives that will enhance the ACCEL Program’s ability to address health inequities and improve
infrastructure for clinical and translational research within the state of Delaware.

Public health relevance
Project Narrative Please refer to the overall section.